Cognitive and Neural Strategies for Latent Feature Inference

PROJECT SUMMARY
The world around us has a statistical structure that we can use to improve our choices. Learning the underlying
structure by identifying key features, such as the rate of change, is useful for adapting and optimizing our
decision-making strategies. However, learning these features requires accumulating evidence across multiple
timescales: a short timescale that considers explicit evidence for the current decision, and a long timescale that
supports latent environmental feature inference. In the brain, evidence accumulation across timescales
necessary for flexible decision-making should therefore engage contextual memory in regions such as
hippocampus (HC). This proposal aims to identify cognitive strategies and neural mechanisms humans
use to accumulate evidence across timescales for adaptive decision-making. Using an interdisciplinary
approach that utilizes computational modeling to develop and validate human behavioral and human
electrophysiological experiments, I will 1) identify the variety of decision strategies humans use to support
multi-timescale inference, 2) model plausible neural mechanisms of human cognitive strategies, and 3) define
HC’s role in implementing multi-timescale inference. This work is in line with the BRAIN initiative’s mission to
link behavior and function and priority research areas 5 (Theory and Data Analysis tools) and 6 (Human
Neuroscience). With my outstanding mentor team, who have combined expertise in theory and experimental
work, the mentored phase of this grant will provide me with 1) additional research skills in both static
inference models and neural-circuit modeling and 2) career development through personalized mentorship,
writing, and scientific communication training. The University of Colorado Boulder offers an ideal environment
for this work, with numerous resources between the departments of Applied Math, Psychology and Institute for
Cognitive Science. Additionally, with the availability of many programs and seminars online, resources at
co-mentor institutions University of Pennsylvania and University of Houston are also accessible. The
independent phase research will combine this additional training with my previous experience in human
electrophysiology and signal processing to study the role of HC in flexible decision-making, analyzing human
neural recordings from epilepsy patients while they perform a multi-timescale decision-making task recorded
by my collaborators at University of Utah. My long term goals are to launch my own lab that applies a
multimodal approach of theory, human behavior, and human neural electrophysiology to identifying the
cognitive and neural strategies associated with flexible decision-making and the impacts that pathological
disruptions have on these processes.

Public health relevance
PROJECT NARRATIVE This proposal aims to identify cognitive strategies and brain mechanisms that humans use to learn about their environment and update the decision-making strategies. Since many neurological disorders impact decision-making, understanding the (diversity of) strategies humans apply to relate their decision-making process to their environment and how these strategies are enacted by the brain is the first step to identifying mechanisms of dysfunction and producing translational treatments and diagnostics. By applying an interdisciplinary approach of computational modeling, behavioral experiments, and human brain recordings, this work can improve our understanding of flexible decision-making, linking behavior to neural activity in a systematic way that sets the groundwork for future endeavors into human cognition and deficits in it.